LifeÃ¢ÂÂs end Benefits of CannaBidol and TetrahYdrocannabinol (LiBBY) Trial

Project Summary / Abstract
This project will be conducted in the context of the Alzheimer’s Clinical Trials Consortium
(ACTC), which is a consulting group of over 100 sites (with 30 leading clinical sites in the
Steering Committee) dedicated to Alzheimer’s disease (AD) research and the infrastructures
supported by the National Institute on Aging (NIA). The goal of this research project is to
develop safe and effective approaches for the treatment of hospice care-eligible, agitated
subjects suffering from AD or other types of dementia (HAAD). Today, half of the subjects
suffering from AD and other types of dementia will use hospice care in the last days of their life.
In most cases, over 73% of them will require the use of psychoactive medications for the
treatment of agitation. There is currently no approved treatment or body of research to guide
physicians in the treatment of these very difficult patients. In the absence of appropriate
evidence based guidelines, patients are usually treated with a combination of anti-psychotics,
benzodiazepines, and opiates. However, these agents generate a variety of side effects
including confusion, constipation, pruritus, and other neurological adverse events, such as
tremors and muscular spasms. The aim of this project is to test the efficacy of an oral
combination of two cannabinoids, tetrahydrocannabinol (THC) and cannabidiol (CBD), for the
treatment of agitation in HAAD.
This study is based on data from a preliminary, double-blind, placebo-controlled, cross-over
study in a similar population using nabilone; a synthetic derivative of THC and an agonist at
cannabinoid receptors CB1 and CB2 that showed statistically significant benefits on measures
of agitation in a population similar to HAAD patients. In the current proposal, we have chosen to
use a combination of THC and CBD oils because of the enhanced synergistic effects that the
combination can provide while maintaining a low side effects profile.
We propose a 12-week, phase 2, multicenter, randomized, double-blind, parallel-group,
placebo-controlled study in HAAD patients, with primary outcomes evaluating the efficacy and
tolerability of a THC/CBD oral combination at week 2 and week 12. A total daily dose of 8 mg of
THC and 400 mg of CBD dissolved in digestible oil will be administered 2 times per day with a
maximum of 4 mg of THC and 200 mg of CBD per dose. The study will recruit 150 HAAD
subjects from 15 USA sites over a 2-year period. To facilitate recruitment and retention and to
monitor long-term safety of the THC/CBD combination, completers of the double-blind study, will
then have the option to participate in a 6-month, open-label extension study.

Public health relevance
Project Narrative Today, approximately 9 million people are suffering from Alzheimer’s disease and other dementias. Unfortunately, there is no approved treatment to manage these patients, nor research to guide the doctors in their care. The goal of this study is to test the usefulness of a combination of two medications extracted from marijuana plant for the treatment of this condition.